A Confirmatory Efficacy Study of Interoceptive Exposure for Adolescents with Low Weight Eating Disorders

Project Summary/Abstract
Low weight eating disorders, such as anorexia nervosa/atypical anorexia nervosa, are severe psychiatric
disorders that often develop in adolescence, have a chronic course, and evidence poor response to treatment
at great public health cost. Two core features of LW-EDs are food avoidance and preoccupation with shape
and weight. Preliminary data from our initial mechanism study indicate that family based interoceptive
exposure (FBT-E) therapy reduces food avoidance, increases autonomous eating and nonjudgement body
awareness, and enhances extinction learning to aversive food cues to a greater degree than existing family-
based therapy (FBT). Feasibility data indicated high retention, treatment fidelity, and established reliable
measures of treatment adherence despite similar short-term (6-week) within-treatment changes in expected
body weight. Long-term (6-month) follow-up of these interventions in open trial indicate significantly higher
expected body weight among those having received FBT-E. Short-term and long-term changes in weight were
highly correlated with changes in expected body weight. Consequently, we will test the confirmatory efficacy of
FBT-E vs FBT and 12-month follow-up in a parallel group randomized clinical controlled trial in 120
adolescents aged 12-18. We have three specific aims, including: (1) to determine short term and long term
efficacy of FBT-E vs FBT in expected body weight, global eating disorder symptoms, and clinical impairment;
(2) to determine efficacy of FBT-E vs. FBT on laboratory measures of autonomous eating, nonjudgmental body
awareness, and extinction learning; and (3) estimate whether temporal precedence and mechanistic value
(mediation) of early changes in autonomous eating, non-judgmental body awareness, and extinction learning
on treatment effects and longitudinal outcomes. Assessments and data analyses will be blinded to treatment.
With N=120 participants (n = 60 per group) we can detect moderate sized effects for primary and secondary
outcomes. Results will provide data to support novel treatment for LW-EDs and provide theoretical robust
model for understanding pathology for children and families that suffer with LW-EDs.

Public health relevance
Project Narrative This project will test the efficacy and 12 month follow-up of a family-based therapy that uses specialized exposure to bodily cues compared to family therapy that focuses on taking control of child refeeding. Preliminary data suggests that family therapy with exposure increases autonomous eating and reduced judgmental body evaluation. This study will determine if these changes are the mechanism for treatment changes.